Targeting hepatic stellate cell metabolism to treat steatotic liver disease

PROJECT ABSTRACT / SUMMARY
Hepatic stellate cells (HSC) are fibroblasts of the liver that are normally localized in the perisinusoidal
space of the lobule. In response to liver injury, secreted factors from hepatocytes, macrophages, and other
cells trigger a program of activation in HSC. Activated HSC proliferate and migrate to sites of injury and begin
secreting components of the extracellular matrix including collagens and other extracellular proteins that make
up fibrotic lesions. While HSC activation is important for maintaining liver structural homeostasis and injury
repair, the chronic, unrestrained activation of HSC can lead to cirrhosis and liver failure. Prior research
conducted in vitro has suggested that high rates of metabolic flux are required to support proliferation,
migration, and production and secretion of extracellular matrix proteins by HSC. Glucose uptake and utilization
are robustly increased in HSC by activating stimuli. Work conducted during the prior period of support
demonstrated that inhibition of the mitochondrial pyruvate carrier (MPC), which prevented mitochondrial
metabolism of pyruvate, an end product of glycolysis, diminished HSC activation in vitro and in vivo. Glutamine
is another important metabolic substrate in HSC and serves not only as a TCA cycle input through
glutaminolysis, but also as a precursor for proline and other amino acids that are enriched in collagen. Our
preliminary data demonstrate that inhibition of either the MPC or glutaminolysis is sufficient to attenuate
stellate cell activation. Since inhibitors of the MPC and glutaminolysis are in clinical development, these
findings suggest a viable way to target HSC activation by metabolic modulation. However, a mechanistic
understanding of how modifying mitochondrial metabolism inhibits HSC activation is still lacking.
The goal of this application is to understand the metabolic and molecular mechanisms by which inhibiting
mitochondrial pyruvate and glutamine metabolism suppress HSC activation. We have hypothesized that the
hypoxia inducible factor 1α (HIF1α) transcription factor is regulated by mitochondrial metabolism and plays a
key role in HSC activation in metabolic dysfunction-associated steatotic liver disease (MASLD). The proposed
work will dissect the mechanisms by which mitochondrial metabolism regulates HIF1α stability and examine
whether HIF1α inactivation in HSC abrogates the development of fibrosis in mouse models of MASLD. In
addition, we will examine how modulating mitochondrial metabolism influences the interactions between HSC
and other parenchymal and non-parenchymal cells of the liver and verify some of our findings in human
subjects with MASLD. These studies will markedly advance our understanding of HSC metabolism in vivo,
provide a wealth of new information for the field, and potentially identify metabolic vulnerabilities as novel
therapeutic targets.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease (MASLD) is very common in people with obesity and is a serious public health problem. This project is designed to gain a better understanding of metabolism in hepatic stellate cells, which play a role in the progression of liver fibrosis in MASLD. We will also test whether modulating mitochondrial metabolism in stellate cells might be a new way to treat MASLD.